Assessing psychosis-related deficits based on gaze behavior

? DESCRIPTION (provided by applicant): Assessing psychosis-related deficits based on gaze behavior Existing tests of psychotic disorders are either functionally-informative or biologically-valid, but rarely both. The ultimate project goal is to improve behavioral health and reduce societal costs by providing a battery of user-friendly tests that offer functional relevance couple with biological validity. This project aims to establish the feasibility of using gaze measures as trait and state markers of psychosis.

Public health relevance
PUBLIC HEALTH RELEVANCE: Assessing psychosis-related deficits based on gaze behavior Existing tests of psychotic disorders are either functionally-informative or biologically-valid, bu rarely both. The ultimate project goal is to improve behavioral health and reduce societal costs by providing a battery of user-friendly tests that offer functional relevance coupled with biologicl validity. This project aims to establish the feasibility of using gaze measures as trait and state markers of psychosis.